Occupational Health Internship Program

Abstract-Occupational Health Internship Program
The primary goal of the OHIP program is to identify and provide training for the next generation
of occupational health professionals. Three major training objectives underlie the program.
Over the course of a summer, each of the OHIP trainees gains an understanding of:
• The importance of work-related health and safety hazards in determining the health of
workers and the general community;
• The changing nature of the workforce and importance of designing health and safety
interventions to meet the needs of specific and diverse worker groups; and
• The role of occupational health and safety professionals in reducing workplace health and
safety hazards.
The second goal of OHIP is to increase diversity in the occupational health disciplines by
aggressively recruiting and mentoring students from minority and immigrant backgrounds.
Many of the over 400 applicants we receive each year are from underrepresented minorities
(URMs), and the majority we accept into the program are from diverse ethnic and
socioeconomic backgrounds. Of the 284 students over the fourteen years of the program, 70%
percent were from diverse ethnic and socioeconomic backgrounds. Fifty percent of them would
be included in the URM category. In addition, 82% of all OHIP students are fluent in a second
language and 14% speak a third language. Thus, many of our students bring special language
and cultural skills that are essential to the success of the project. In addition, the majority of our
field-based projects serve low wage and immigrant worker populations.
Each OHIP team completes three “deliverables” during their 9-week project: (1) Educational
materials that can be used by their host organization (union, community based organization,
agency, etc.) to improve worker knowledge of safety and health hazards; (2) Summary of their
findings in PowerPoint format to be presented at the end of the summer through
videoconference links; and (3) Written summary reports of project objectives, methods, results
and recommendations.
OHIP project personnel and mentors from around the country, each with considerable health
and safety experience, work to ensure that the internships will be successful. This includes
extensive national recruitment for applicants, careful selection of student projects, organization
of a three-day national orientation training, and effective mentorship and supervision throughout
the summer. Post-summer communication with the trainees solidifies their interest in
occupational health. A national advisory board composed of nationally recognized educators
and scientists continues to play a key role in overseeing the program.

Public health relevance
Narrative-Short The primary goal of the OHIP program is to identify and provide training for the next generation of occupational health professionals. The second goal of OHIP is to increase diversity in the occupational health disciplines by aggressively recruiting and mentoring students from minority and immigrant backgrounds.